Research Training in Vision Science

ABSTRACT
This application seeks five years' continued funding for a training program supporting four pre-doctoral
students with the aim of producing independent investigators capable of sustaining productive research
programs in the vision sciences. The program is designed for training students in the areas of molecular/cellular
biology, genetics, biochemistry, biomedical engineering, machine learning, and immunology with particular focus
on training in vision research. Mentors have been selected with an emphasis both on the productivity of their
current research and on their training records. The training program is organized to rigorously instruct and
reinforce skills pertinent to experimental science and involves a combination of coursework, independent
research, oral presentations (in-house, national and international), written research proposals, and the
sharpening of communication skills through continuous mentor feedback and peer review.
The program is interdisciplinary and utilizes a core group of thirteen mentors with active research and
training programs whose primary and joint appointments span four colleges (Medicine, Liberal Arts and
Sciences, Engineering, and Veterinary Medicine). The Department of Ophthalmology serves as the
administrative and logistical center for this vision science training program, but individual faculty preceptors
maintain primary graduate training appointments in the Departments of Molecular Genetics and Microbiology,
Neuroscience, Pediatrics, Immunology, Pharmacology, Biomedical Engineering, Small Animal Veterinary
Sciences, and Psychology. The Department of Ophthalmology adds depth to the program by providing exposure
to current problems in clinical ophthalmology in order to acquaint the pre-doctoral students with relevant clinical
issues in vision. Overall, we propose an integrated program of research training and professional development
aimed at producing independent investigators capable of sustaining productive, innovative, independent
research programs in the vision sciences.

Public health relevance
NARRATIVE Blinding diseases are some of the most devastating health concerns in the United States. This training program seeks to produce independent investigators capable of sustaining productive, innovative, independent research programs in the vision sciences. These new scientists are expected to generate discoveries in the underlying mechanisms of vision and associated pathologies, and to help develop treatments for these diseases.